2024 Intermediate Filaments Gordon Research Conference and Seminar

Summary
Intermediate filament (IF) proteins are encoded by over 70 distinct genes, placing them among the largest
gene families in humans. Members of the IF protein family have diverse functions in virtually all cell types.
They serve as critical components of the cytoskeleton and nucleoskeleton and act as sensors, modulators, and
integrators of other key structural and regulatory proteins. Mutations in genes encoding IF proteins cause a
wide range of diseases, including skin diseases, muscular dystrophy, cardiomyopathy, premature aging
syndromes, and neurodegenerative disorders. Abnormal assemblies of IFs are hallmarks of and biomarkers for
cancer neurodegenerative disorders, and liver diseases. Given the diverse functions of IF proteins, their
interactions with other cellular components, and their disease relevance, close collaborations between basic
researchers and translational investigators spanning multiple disciplines are necessary to overcome current
challenges in the field. Bringing together such diverse scientists will provide new insights into the physiological
functions of IFs and foster the development of novel therapeutic approaches for IF-related diseases. Towards
this goal, this application requests funds to support the June 2024 Gordon Research Conference (GRC) and
Gordon Research Seminar (GRS) on IFs to be held at Rey Don Jaime Grand Hotel, located just outside
Barcelona in Castelldefels, Spain. We have organized a stimulating program of scientific sessions in an
environment that is conducive to concentrated discussion and debate, as well as informal interactions and
networking. The speakers and other attendees will be established, mid-career, and early-career scientists as
well as students and trainees from diverse backgrounds representing multiple disciplines. Aim 1 is to provide
an interdisciplinary forum for the discussion of the best and most recent research on IFs, and their relationship
to cell physiology and disease. Aim 2 is to highlight novel scientific themes relevant to IF research, which will
be accomplished by including novel scientific sessions and inviting several speakers outside of the traditional
IF community to promote new ideas and approaches. Aim 3 is to promote formal and informal scientific
exchanges on IF biology between investigators across the whole career spectrum. Graduate students and
postdoctoral researchers will also be able to participate in the GRS immediately prior to the GRC. The GRS is
run solely by graduate students and postdoctoral scientists studying IFs. To enhance interactions, each day of
the GRC and GRS will provide numerous opportunities for informal exchanges among participants, including
shared meals, free afternoons, poster sessions, and evening social times. The broad long-term objectives of
the GRC and GRS are to grow the IF community and to provide forums for the exchange of ideas among
scientists at all career stages interested in IFs, a family of proteins that are understudied despite their
significant impact on major areas of public health.

Public health relevance
Narrative Intermediate filaments (IFs) are a family of intracellular proteins involved in numerous functions. Mutations in genes encoding IF proteins cause over 100 human diseases that affect major organs, including skin, skeletal muscle, bone, heart, brain, nerves, and the vasculature, as well as aspects of aging. The 2024 Gordon Research Conference on IFs, together with the accompanying Gordon Research Seminar, will bring together scientists from around the world and across the career spectrum to discuss recent discoveries in the field.